TB/MDR-TB Research training and Capacity Strengthening for LMIC in Southeast Asia Phase II

PROJECT SUMMARY
This grant application is the renewal of the D43TW009522 training program in its second phase for another 5
years. The training program's plan is to strengthen TB research capacity, especially human resources of TB
research at collaborating centers in low and middle-income (LMIC) countries in Southeast Asia, namely:
Department of Medical Research, University of Public Health, University of Community Health and the National
TB Program, Myanmar; University of North Sumatra, Andalas University, Riau University, Syiah Kuala
University and the TB Research Network of Indonesia (JetSet); National TB Program and Department of
Medical Science Thailand. The training program will have a focus on TB. The program objectives are to train
researchers from collaborating centers in Indonesia, Myanmar and Thailand to earn the degrees of MSc/PhD
in Epidemiology at Prince of Songkla University (EPI-PSU), to provide short-course training in TB
Epidemiology/Biostatistics and TB laboratory science to various researchers of the collaborating centers. The
long-term training to produce 8 PhD and 7 MSc graduates will be based at EPI-PSU. We will also train extra 20
trainees in 1 month training in TB Microbiology at Siriraj Hospital and Faculty of Science of Mahidol University
(TB-MU), and extra 21 fellows in short course in TB Epidemiology at EPI-PSU. To enhance the capacity of the
collaborating centers, our alumni and we will run research training workshops in Indonesia and in Myanmar
and engage into the National and International TB Research Network. Our alumni will collaboratively develop
and submit appropriate collaborative TB research proposals for funding. All long-term trainees will be initially
selected by the collaborating institutes, and revised by a Training Advisory Group (TAG). The long-term
training curriculum consists of one-year coursework (for PhD and MSc programs alike), emphasizing
epidemiology/biostatistics, research methodology, responsible conduct of research, and data analysis. This is
followed by data collection for research thesis related to TB (1 year for PhD and 6 months for MSc) at home
institutes of the trainees. Finally, another year for the PhD and 6 months for the MSc trainees will be spent on
data analysis and report writing at EPI-PSU. Apart from technical quality, arrangements have been made to
ensure diversity of trainees, maximum retention and continuation of research career development after the
training has been completed.

Public health relevance
PROJECT NARRATIVE Within the tuberculosis (TB) endemic areas in Southeast Asia, Prince of Songkla University and Mahidol University, Thailand and Methodist Hospital, Houston, Texas, will provide a degree- granting and research training program related to the epidemiology of TB, to build research and disease control capacity in Myanmar, Indonesia, and Thailand. The Fogarty International Center's support will allow the regional network of institutes to strengthen their capacity, especially on human resources for research. After five years of the program, there will be altogether 56 researchers from these three countries trained at Doctoral, Master, and short- course level.